Nanoscale programming of celluar and physiological phenotypes

ABSTRACT
The foundation for our funded MIRA grant 1R35 GM134864 was the concept of a nanocomputing agent (NCA),
a protein-based device whose function is responsive to specific stimuli. Specifically, we proposed designing
computing devices based on a single protein, the function of which was “conditioned” on a set of extracellular
or intracellular instructions. Our grand intent is to design subcellular molecular controllers of cellular phenotype
that can be exploited in a variety of biomedical and pathological settings (like cancer or Alzheimer’s disease).
The function of this protein follows the logic imposed by the communicated or sensed instructions. Hence, the
manipulation of the input signals allows a computation to be performed by the engineered protein.
Conceptually, the NCA agent is controlled by engineered response units (RUs) into target proteins, which
sense diverse signals, such as light, small molecules (e.g., drugs), RNAs, proteins, and pH. Some RUs are
natural, such as the LOV2 protein that responds to blue light by undergoing order-disorder transition, while
some RUs are engineered, such as uniRapR which undergoes disorder-to-order transition upon binding a
small ligand. The modularity of the NCA design allows for programmable control of arbitrary biological systems
using desired external and internal queues. Over the past four years, we have made significant progress in the
proposed directions to create functional NCAs. Not only were we able to create the first-ever single protein-
based logic gate, but we also built the first-ever circuit featuring non-commutative logic displayed by a single
protein. While we did not anticipate such rapid success with our tools, these proof-of-concept NCAs
demonstrate the feasibility of the methodology. Furthermore, the biological findings based on the developed
NCAs allowed us to develop several translational biomedical applications, including a new cancer
immunotherapy approach that we are testing in melanoma mice models. Here, we propose to continue
developing computational and experimental tools for rapidly designing and deploying NCAs for a wide range of
applications. We will use molecular modeling, simulations, machine learning, and macromolecular design in
combination with experimental studies of engineered biomolecules. Specifically, we plan to (1) develop a
computational platform for designing allosteric wiring in proteins; (2) develop a repertoire of robust input
triggers (RUs), specifically focusing on designing a small pH-sensing domain; and (3) develop a computational
platform for RNA design. In addition, we plan to continue applying our technology to various biomedical
systems with numerous collaborators. These directions highlight our shorter-term (5-year) goals towards our
long-term vision of developing robust Lego-like NCA systems that enable precise control of cellular phenotype.

Public health relevance
PROJECT NARRATIVE We plan to continue developing a radically new technology for molecular computation, whereby molecules themselves respond to external stimuli and produce output at the level of cellular phenotype, serving as nanocomputing agents (NCAs). The advent of such NCAs would revolutionize the interrogation of biological systems, enable a deeper understanding of human biology and disease, and facilitate the development of in situ precision therapeutics.